Developmental origins of cancer

We have three subprojects to report. 1. Leveraging temporal transcriptomic data during development in multiple human organs, we demonstrate that the 'embryonic positive (EP)' alternative splicing events, specifically active during human organogenesis, are broadly reactivated in the organ-specific tumor. EP events are associated with key oncogenic processes and their reactivation predicts proliferation rates in cancer cell lines as well as patient survival. EP exons are significantly enriched for nitrosylation and transmembrane domains coordinately regulating splicing in multiple genes involved in intracellular transport and N-linked glycosylation respectively, known critical players in cancer. We infer critical splicing factors (CSF) potentially regulating these EP events and show that CSFs exhibit copy number amplifications in cancer, are mutational hotspots and somatic drivers in multiple cancer types and upregulated specifically in malignant cells in the tumor microenvironment. Mutational inactivation of CSFs in cancer patients and shRNA knockdown in HepG2 cell line results in decreased EP splicing, supporting their causal role. Multiple complementary analyses point to MYC and FOXM1 as potential transcriptional regulators of CSFs in brain and liver, which can be potentially targeted using FDA approved drugs. Our study provides the first comprehensive demonstration of a splicing-mediated link between development and cancer, and suggest novel targets including splicing events, splicing factors, and transcription factors. This work was published in Nat Communications. 2. In collaboration with Merlino lab@NCI we have analyzed the in-house single cell transcriptomics data of developing melanoblasts in mouse at 2 developmental timepoints - E11.5 and E15.5. We have identified several cellular states among the developing melanoblasts and show that some of the Schwann cell progenitor and Mesenchymal states are recapitulated in the melanoma metastasis. Through an extensive analysis of publicly available data we show that these states are associated with patient survival in human melanoma and are associated with vemurafenib and ICB resistance. The manuscript was deposited in BioRXiv and . 3. As a side project, we have also started analyzing the links between oncogenesis and three key homeostatic processes, namely, Stress response, Wound Healing, and Regeneration. We have compiled genes associated with these processes from original perturbation experiments in multiple species. We show that indeed known human cancer drivers highly overlap with these processes, are proximal to these processes in the protein-interaction network, and very interestingly, we show that based simply on the proximity from these processes in the protein interaction network, we can predict known cancer drivers from other genes. We are currently writing a manuscript reporting this work. 4. Following up on our Nat Comm work (#1 above), we are launched a new project exploring the rolw of alternative splicing in cancer drug response and resistance.